Neural coding of language semantics and speaker identity during speech comprehension

Project Abstract
Effective communication requires understanding both the meaning of spoken words (semantics) and the
identity of the speaker. This integration of semantics and speaker identity is vital for social interactions, yet the
neural mechanisms supporting this process are not fully understood. This project investigates how the anterior
cingulate cortex (ACC), a region involved with both language and social cognition, contributes to the integration
of semantic content and speaker identity during natural conversations and speech comprehension. We propose
that the ACC encodes semantics and speaker identity using distinct but related neural population subspaces,
allowing efficient generalization across different speakers while maintaining specificity. To test this hypothesis,
we will record single-neuron activity in the ACC of patients with epilepsy during both passive listening to podcast
stories and active participation in natural conversations. Our specific aims are to delineate how ACC neurons
respond to different semantic categories and speakers (Aim 1) and to determine how neural populations align
these semantic representations across different speakers using neural subspace analysis (Aim 2). Our findings
will have important implications for basic science research and understanding of communication disorders. This
study will provide new insights into the neural coding of language and social information, improving the
development of assistive communication technologies and neural prosthetics aimed at individuals with language
impairments, such as those with autism or aphasia. Collectively, this proposal aims to elucidate single neuron
dynamics in real-life communication and will provide me with the skills needed to continue social communication
and language neuroscience research as a principal investigator.

Public health relevance
Project Narrative This research aims to uncover how the brain integrates the meaning of words with the identity of the speaker during speech comprehension. The research leverages the unique opportunity to record from single neurons in humans during natural conversations. Understanding this integration process in the anterior cingulate cortex will provide crucial insights into how communication functions and how it may be impaired in conditions like autism and aphasia, ultimately informing the development of assistive technologies and therapies for individuals with communication deficits.